Gaining insight into psychiatric disease by engineering piece by piece the human brain in vitro

ABSTRACT
The inaccessibility of human brain tissue at the molecular and cellular level has hindered
therapeutic development for psychiatric disorders. Our laboratory has developed neural
organoids mimicking specific brain regions from stem cells and pioneered neural assembloids to
study interneuron migration and circuit formation. However, in vitro models lack the in vivo
interactions and inputs necessary for complex neuropsychiatric disease modeling. We now
propose generating assembloids within the in vivo rodent cortex to enhance neuronal maturation
and behavioral readouts. Specifically, we will expand transplantation models by integrating
glutamatergic and GABAergic neurons to model excitation-inhibition imbalances and early cortical
circuit formation. We will establish transplanted forebrain assembloids, characterize their
integration and functionality, and apply this model to study severe neurodevelopmental disorders
caused by genetic mutations.

Public health relevance
NARRATIVE The slow pace of progress in understanding brain disorders is partly due to the lack of access to live neurons from patients for detailed investigation through imaging, recording, and stimulation. To address this challenge, we propose to build a next-generation in vivo transplantation model using human stem cell-derived assembloids. This novel system will enable us to study the development of human neural circuits and how these processes go awry in genetic neurodevelopmental diseases.